STRUCTURE AND FUNCTION OF A PURINE BIOSYNTHETIC ENZYME

This primary objective of the proposed research is to understand the control of the biochemical pathway for de novo biosynthesis of purine nucleotides. Specifically, this goal will be accomplished by determining the three-dimensional structure of glutamine PRPP amidotransferase, the enzyme that catalyzes the first and committed reaction in the pathway. Changes to the structure caused by inhibitor and activator molecules will also be determined. Most of the regulation of the purine biosynthetic pathway is directed towards this enzyme and a solid understanding of its structure and its reaction with effector molecules is critical to understanding regulation of the entire pathway. The health relatedness of the proposed research is twofold. Defects in the purine biosynthetic pathway have been associated with disorders such as hyperuricemia (gout), immunodeficiency and neurological symptoms. Secondly, components of the pathway, especially glutamine PRPP amidotransferase, are targets for the design of anticancer drugs due to the high rate of purine biosynthesis required by rapidly dividing cells. Glutamine PRPP amidotransferase contains an essential inorganic FeS center that apparently has a novel regulatory function and is not catalytic. The three-dimensional structure of the enzyme should clarify the role of this unusual metal center. The three-dimensional structure will be determined by X-ray crystallography and the structure determination should be a significant advance for the new crystallographic technology of multiwavelength anomalous dispersion. Successful application of this methodology to the glutamine PRPP amidotransferase structure will be a significant step towards proving its generality as a rapid and accurate means of structure determination for biological macromolecules.